The Population Research Institute: Administrative Core

The Administrative core is the organizational hub of the Population Research Institute (PRI) and supports
research in all of PRI’s primary research areas to advance the scientific understanding of human population
dynamics. The Administrative core coordinates activities and manages general operations. The Administrative
core provides leadership and management that ensures PRI functions as an engaging setting for research
collaboration and dissemination. The core is directed by the PRI Director and the Managing Director. The
Administrative core’s specific aims are focused on maximizing research efficiency and minimizing
administrative burden for researchers. The specific aims of the Administrative core are: (1) To manage PRI’s
general operations including financial resources, facilities and staff vital to supporting the scientific mission of
PRI; (2) To provide comprehensive services from project inception to completion that increase research
productivity and impact; (3) To coordinate the administrative needs for interdisciplinary research teams that
span institutions and include population scientists beyond PRI; (4) To advocate for resources and disseminate
PRI’s contributions to population science within the Pennsylvania State University and in the scientific
community more broadly. The activities of the Administrative core are designed to improve the productivity and
impact of population science research across PRI’s four primary research areas and reduce administrative
burden for researchers. Through efficient management processes, the Administrative core increases
researchers’ competitiveness for external funding and raises the impact of their research on improvements in
human population health and wellbeing.

Public health relevance
Project Narrative – Administrative Core. Not applicable